Project 3

PROJECT 3 SUMMARY
Immune checkpoint inhibitors have transformed melanoma treatment, producing durable responses, prolonged
survival, and clinical benefit in a significant proportion of patients. Moreover, they delay recurrence and extend
survival in the adjuvant melanoma setting, and have also shown efficacy in a range of different cancer types.
However, immune checkpoint inhibition (ICI) therapy can also be accompanied by immune-related adverse
events (irAEs) that impact multiple organs, cause significant morbidity, and require immunosuppression or
discontinuation of ICI treatment. There is an urgent need to identify patients who will develop severe irAEs from
ICI. This would enable us to optimize treatment selection and sequencing, justify preventive strategies to mitigate
toxicity, and better manage toxicities. While there is intense interest in identifying markers to predict response to
ICI, no pre-treatment biomarker tool can predict irAEs associated with ICI for any cancer type. The goal of our
project is to develop a predictive tool that enables clinicians to minimize exposure of patients to severe
toxicity, while maximizing clinical benefit from ICI.
We hypothesize that a subset of melanoma patients has a baseline, sub-clinical autoimmune
susceptibility, characterized by specific pre-existing autoantibodies (autoAbs) that can predict and
exacerbate the development of toxicity from ICI therapy. We have identified autoAb signatures in baseline
(pre-treatment) sera that predict severe immune toxicity in melanoma patients treated with ICI (AUC >0.95).
Using a humanized mouse model, we found that autoAbs from baseline sera of melanoma patients can
exacerbate irAEs from ICI. In this project, we propose to refine and validate baseline autoAb biomarker
signatures of ICI toxicity using sera (n=600) from two large adjuvant ICI clinical trials for resected stage-III/IV
melanoma (Aim 1). To understand the relevance of specific autoAbs to common irAEs (e.g., colitis) and to
investigate an autoimmune predisposition in some patients, we will compare irAE-associated autoAbs with those
from inflammatory bowel disease patients and from normal donors. We will use our humanized FcR mouse
model to determine the cause-effect relationship between autoAbs and irAEs, with a focus on colitis, and for
preclinical testing of prophylactic anti-TNF- as a strategy to mitigate gastrointestinal (GI) toxicity from ICI (Aim
2). These findings will inform a biomarker-driven phase-II trial of prophylactic anti-TNF- (infliximab) in patients
receiving ICI therapy who are at high risk for developing severe diarrhea and colitis (Aim 3).
Our work will inform personalized melanoma treatment strategies by validating a robust pre-treatment biomarker
to enable clinicians to optimize ICI regimens and minimize patient exposure to severe irAEs. We will both identify
an autoimmune susceptibility to irAE development and establish whether prophylactic TNF- blockade mitigates
development of GI toxicity from ICI in patients identified as being at high risk of these irAEs.

Public health relevance
PROJECT 3 NARRATIVE Project 3 has three key goals: 1) Refine and clinically validate a baseline autoantibody signature that identifies melanoma patients at high risk of developing severe immune toxicity from immune checkpoint inhibitors, using pre-treatment sera. 2) Identify a causative role for baseline autoantibodies in toxicity development. 3) Conduct a biomarker-driven phase-II clinical trial testing prophylactic anti-TNF- to mitigate development of immune toxicity from checkpoint inhibitors in patients at high risk of immune-related adverse events.